Enhancing Mentoring of Diverse Early Career Researchers

Project Summary/Abstract
Recruitment and retention of women and underrepresented minorities into academic
gastroenterology (GI) has been a major challenge for decades (Merchant, 2010). Indeed, as of
2017, only 3.2% of gastroenterology fellows were African American and 8.5% were Hispanic
(Quezada, 2017). To address these challenges NIDDK has funded initiatives by the American
Gastroenterology Association (AGA) since 2012: R25 DK096968 Investing in the Future to
Promote Diversity in GI Training (9/10/2012 – 8/31/2017) and R25 DK118761 AGA - Fostering
Opportunities Resulting in Workforce and Research Diversity (FORWARD, R25 DK118761
7/1/2018 – 4/30/2023). FORWARD is a structured curriculum that has been successful in helping
junior GI faculty from URM backgrounds (twenty so far) to succeed in academia. Its renewal for
the next 5 years has received a favorable score. For the past ten years this PI and others at
AGA, who are passionate about diversity, have volunteered their time to compete for funding,
organize, coordinate and supervise the progress of these NIDDK-funded initiatives. This K26
award will provide dedicated salary support to allow this investigator to decrease his clinical load
and reallocate salary support to hire a senior scientist to assist the PI with the day-to-day operation
of his research program. These measures will for the first time allow the PI the dedicated time
that might better guarantee the success of these national initiatives. At the institutional level, these
funds will free time to continue mentoring URM students at the undergraduate and graduate levels
and newly hired junior GI faculty.

Public health relevance
Project Narrative Recruitment and retention of women and underrepresented minorities into academic gastroenterology (GI) has been a major challenge for decades. NIDDK has supported efforts by the American Gastroenterology Association (AGA) from 2012 through 2023 through the R25 mechanism. I have been involved in these efforts for decades at the local (UCSD) and national levels. The latest of these R25 DK118761 AGA - Fostering Opportunities Resulting in Workforce and Research Diversity (FORWARD) provides a structured mentoring program for junior GI faculty. The program has provided structured mentoring to 20 junior academic GI’s and has received an excellent score for the next 5-year cycle renewal. I have been involved in these efforts for decades at the local (UCSD) and national levels. This award will provide dedicated salary support to allow this investigator to reallocate effort to these diversity initiatives both at UCSD and with the AGA.